Training in Gastroenterology

Abstract
The long-term objective of the Vanderbilt Training in Gastroenterology T32 Program is to identify, recruit,
train, and mentor a diverse workforce of compassionate and dedicated investigators by providing a rigorous
scientific foundation in 1) basic research, to reveal new disease mechanisms and identify novel therapeutic
targets; or 2) clinical/translational research, with the opportunity for formal studies in clinical science,
epidemiology, or informatics. Richard Peek serves as Director and is assisted by an Associate Director, Keith
Wilson, as well as a Steering Committee and Internal and External Advisory Committees composed of senior
faculty deeply invested in training young investigators and cultivating diversity. The design of this
multidisciplinary program is to support 5 postdoctoral fellows/year (1-2 years in duration) who show exceptional
aptitude for pursuing research careers. Trainees are selected from a curated pool of fellows accepted into the
Gastroenterology training programs, physician-scientist applicants from other clinical training programs, and
applicants that apply directly to preceptor laboratories. A customized mentoring team is constructed for each
trainee consisting of a Mentor with nationally recognized expertise and a Research Advisory Committee to
provide additional guidance, mentoring, and feedback. Each trainee becomes part of a translational research
group that includes basic and clinical investigators (40 Preceptors/10 Departments), enabling an in-depth
understanding of specific diseases from bench-to-bedside. The trainee experience is enriched by an extensive
program of seminars and coursework tailored to meet individual needs and via the Academy of Investigators,
which provides comprehensive career development and a Diversity Program focused on underrepresented
minority (URM) investigators. This T32 is also engrafted into a continuum that provides a wealth of funding
opportunities only available to fellows and junior faculty to facilitate an uninterrupted research focus resulting
from funding stability. In the last 15 years, 51 trainee scientists have been or will be supported by this Program
(33 MD or MD/PhD, 16 PhD, 2 DO); 26 (51%) have been female, and 10 (20%) have been from URM groups.
Further, the number of female trainees and URM trainees increased substantially in the current funding period
(female: n=12, 60%; URM: n=5, 25%) compared to the previous funding period (female: n=5, 36%; URM:
n=1, 7%). At present, 41/51 (80%) of these trainees are pursuing research-intensive or research-related
careers or are still in training, 81% of Program graduates have received research funding and, since 2014, the
average number of publications by all trainees is 16.4/year. Collectively, the unique environment that supports
digestive diseases research at Vanderbilt, catalyzed by rich collaborative interactions between basic and
clinical researchers, a wide range of supporting Cores and Centers, robust institutional support, and exposure
to state-of-the-art clinical care, provides an outstanding opportunity to train successful investigators using a
team-science approach, whose discoveries can be rapidly translated into improved patient care.

Public health relevance
Narrative The Vanderbilt Training in Gastroenterology T32 Program, through mentoring, scientific, financial, and professional support of trainees, seeks to improve the prevention, treatment, and outcomes of human digestive diseases. This Program also serves as a catalyst for collaborative and impactful research performed by a diverse workforce of junior investigators.